Targeting dual functions of PD-L1 for cancer therapy

Abstract
Targeting immune checkpoint signaling with blocking antibodies has reached a limitation in the treatment of
advanced cancers. Although antibodies that bind programmed death ligand 1 (PD-L1) are effective in blocking
PD-L1's extracellular interaction with PD-1 receptor on T cells, the potential adaptive upregulation of PD-L1 and
its recycling from intracellular compartment to the cell surface may compromise their efficacy. Importantly, the
discovery of PD-L1's intracellular functions in cancer cells to promote thier survival and metabolism
also highlight
a mechanism by which tumor cells can gain resistance to cytotoxic therapy and
call for a new strategy to target
PD-L1.
There is therefore a critical need to design, test, and translate new agents that can
simultaneously inhibit
PD-L1's extracellular and intracellular functions.
This application will utilize a new PD-L1 antibody (clone H1A)
that can reduce the expression of PD-L1 in tumor cells through disrupting the association of PD-L1 with CMTM6
(a molecule that can stabilize PD-L1 recycling and expression) and subsequently directing PD-L1 for degradation.
H1A-induced degradation of PD-L1 may not only disrupt PD-1/PD-L1 interactions due to the loss of PD-L1, thus
removing PD-1's suppressive signals in T cells, but also disrupt PD-L1's cell-intrinsic functions within tumor cells
and myeloid cells, thereby decreasing tumor resistance to chemotherapy and releasing the immune-stimulatory
function of myeloid cells. Thus, H1A antibody may be a good candidate for targeting the dual functions of PD-L1
for cancer therapy. Based on preliminary data, the central hypothesis of this proposal is that intracellular signaling
through PD-L1 results in tumor resistance to cytotoxic chemotherapy and limits the immune-stimulatory function
of myeloid cells. Thus, targeted agents that result in degradation of PD-L1 and elimination of its intracellular
signaling ability represent a novel therapeutic strategy that will both synergize with chemotherapy and improve
the immune response. This hypothesis will be tested by pursuing two specific aims: (1) Determine how H1A
antibody synergizes with chemotherapy to overcome tumor resistance; (2) Determine how H1A antibody
promotes an enhanced T cell response to attack tumors. To further assess the future clinical use of H1A antibody,
a fully humanized version of H1A and humanized PD-1 and PD-L1 mice have been produced, which will allow
for evaluation of the therapeutic effects of H1A either alone or in combination with chemotherapy and exploration
of H1A's new mechanism of action in vivo. The overall impact of the proposed research is high because it will
provide a new therapeutic agent that is capable of targeting the dual functions of PD-L1, resulting in improved
efficacy of cytotoxic chemotherapy and an enhanced immune response. This strategy represents a significant
paradigm shift within the field in terms of how to target immune checkpoint molecules like PD-L1 for future clinical
applications.

Public health relevance
Narrative Low responses rate to immune checkpoint blockade cancer therapy prompted us to find new strategy to efficiently target therapeutic molecules on cancer cells and immune cells. We recently discovered a new antibody H1A to PD-L1 that is expressed by both cancer cells and immune cells. We found H1A antibody induced PD-L1 depletion in cancer cells to make cancer cells more sensitive to chemotherapy, and in immune cells to generate strong antitumor immune responses. Our proposed studies will address the synergistic effects of H1A with chemotherapy to overcome cancer resistance to chemotherapy and immunotherapy. The new knowledge and tools produced by our proposed studies will help physicians to treat cancer patients with appropriate combination that would not benefit patients’ clinical outcomes.